Multi-Disciplinary Training Program in the Mechanisms of Cardiometabolic Disease

PROJECT SUMMARY
The objective of the Multi-Disciplinary Training Program in the Mechanisms of Cardio-metabolic Disease is to
provide pre-doctoral scholars with balanced, interdisciplinary training for a successful research career in
integrative cardiovascular research related to minority health. The focus of this training will be on mechanisms
of cardiovascular disease in compromised metabolic and endocrine states. An emphasis in this program
is cardio-metabolic disease common in minorities – hypertension, obesity, and diabetes. The specific goals are:
1) To train the next generation basic and translational scientists in cardiovascular pathophysiology, especially in
states of metabolic dysfunction directly relevant to health problems of minorities, through course work and state-
of-the-art research opportunities; 2) To provide pre-doctoral students with the necessary tools for effective
scientific communication, including networking, grant writing, and formal training in responsible conduct of
research (RCR) to build a competent and ethical research careers; and 3) Actively recruit and train minority
candidates in cardio-metabolic disease research, in part, by leveraging our established connections with
historically black colleges through our prior trainees. These goals will be achieved through the highly integrated
research programs within the Medical College of Georgia (MCG) at Augusta University. MCG-AU has
established itself as a leading national center for basic and clinical science research in cardiovascular disease.
Mentors in the Program come from a variety of basic and clinical research units, including the Departments of
Physiology, Pharmacology & Toxicology, and Cell Biology & Anatomy, Medicine and Pediatrics, including
members of Nephrology, Cardiology, Hematology and Anesthesiology sections. Major interdisciplinary research
units, the Vascular Biology Center (basic science) and the Georgia Prevention Institute are also prominent in the
program. The goal of Program Leadership is to provide expert oversight characterized by excellence in research,
commitment to training and leadership experience both internal and external to the institution. A shared
governance model has been adopted that provides a mechanism of consensus leadership to keep the Program
at the high level we expect for training at MCG-AU. Overall leadership is shared between two co-directors, Drs.
David Stepp and Jennifer Sullivan. Internal Advisory and Admission Committees along with an External Advisory
Committee provide an experienced team of leaders for the program. Pre-doctoral (PhD or MD/PhD) will be
selected based on interest in cardiovascular biology, previous academic performance and research experience.
All students will be required to participate in didactic coursework and a comprehensive set of professional skills
courses including responsible conduct of research, effective scientific communication and networking,
knowledge of technology transfer, scientific writing and review of the literature, preparation and presentations at
local, national, and international conferences, grant writing and review, and leadership skills for subsequent
career stages.

Public health relevance
PROJECT NARRATIVE Cardiometabolic diseases and consequences afflict more Americans, especially minority populations, than all others combined. The understanding of how to deal with this major health problem is critical for the future of America. The current proposal outlines a new training opportunity to prepare early career individuals in the conduct of basic, clinical, and translational cardiometabolic research in a comprehensive, multi-disciplinary fashion.